Sociodemographic predictors of healthcare utilization and adverse outcomes in Medicare beneficiaries with glaucoma

PROJECT SUMMARY/ ABSTRACT
Patients with glaucoma experience an increased risk of adverse health-related outcomes, including falls, injuries,
femur fractures, and depression. In the United States, racial and socioeconomic (SES) disparities exist in
glaucoma prevalence, visual impairment, and eye-care utilization. However, we do not know if these disparities
result in differences in vision- and health-related outcomes between different groups. Furthermore, while it is
known that frailty among older adults has implications for morbidity, mortality, and healthcare costs, the
relationship between frailty and healthcare utilization and outcomes in older adults with glaucoma has not been
explored. We hypothesize that there are detectable differences on the use of eye care services and subsequently
in vision- and health-related outcomes among older adults with glaucoma based on race and SES. We further
hypothesize that older adults with a higher frailty score and more comorbidities will be less likely to use eye care
services and will have worse vision- and health-related outcomes from glaucoma. To address these hypotheses,
we will analyze the existing data from a 5% sample of Medicare beneficiaries from 2014-2016. We will assemble
a cohort of glaucoma patients as well as a matched control cohort. Our analyses are aimed at answering 3
specific aims: 1) are there differences in eyecare utilization among older glaucoma patients based on race, SES
and frailty and is there an interplay between sociodemographic characteristics and frailty? 2) Are glaucoma
patients belonging to vulnerable populations based on race, SES and frailty more likely to experience adverse
vision related outcomes? And finally 3) are there differences in health utilization and adverse outcomes among
glaucoma patients based on their race and SES? We hypothesize that the impact of glaucoma on overall
morbidity and function is unevenly distributed, with vulnerable populations carrying a greater risk or poor health
outcomes. The research outlined here will improve our understanding of the complex interplay of factors
contributing to disparities in glaucoma care and outcomes. This study will enable us to identify gaps in care
among vulnerable populations and identify possible areas for intervention.

Public health relevance
PROJECT NARRATIVE Glaucoma, which is associated with vision-related disability and poor quality of life, disproportionately impacts individuals of low socioeconomic status and those belonging to racial minorities in the United States, but disparities in vision- and health-related outcomes resulting from glaucoma have not been studied. Additionally, the impact of frailty on these outcomes are not clearly understood. Examining the relationship between sociodemographic characteristics, frailty, eye care utilization and vision- and health-related outcomes will identify barriers associated with glaucoma care and have important implications for healthcare policy and patient-specific risk-stratification, ultimately leading to improved outcomes.